Core B Bioinformatics Core

SUMMARY
The Core B. Bioinformatics Core will serve as a comprehensive, multi-disciplinary resource of expertise in
bioinformatics and statistics. It will support the data analysis needs of the program project, collaborating closely
with investigators in the design, management, analysis and exploration of their high throughput omics
experiments. Core B will assist investigators in addressing their aims at all levels to provide insights into age-
related skin regeneration and wound healing through bioinformatics inference. The transcriptomics, DNA
methylation and chromatin accessibility data generated through this program project will be consistently analyzed
using state-of-the-art methods for next generation sequencing analysis implemented in Core B’s infrastructure
that provide rigorous quality control, mapping, and quantitation of genes and genomic regions with functional
roles in skin regeneration. Using established unsupervised and supervised multi-omics integrative approaches,
Core B will identify shared signals across experiments and work with program investigators to map key metabolic,
epigenetic and cell receptor stem cell pathways that drive age-related wound healing dysfunction. The results of
these analyses will be made available through an interactive web based visualization system for storage, retrieval
and exploration of the data generated by the program projects, enabling the achievement of the project aims and
facilitating formulation of new testable hypotheses beyond those stated.